Understanding Cell Behavior in Precise Multifunctional Biomimetic Matrices Prepared via 3D Printing

PROJECT SUMMARY/ABSTRACT
The lack of cell culture strategies that faithfully replicate both form and function of the extracellular matrix (ECM)
hinders our ability to effectively monitor, diagnose, and treat disease. This arises from the contemporary reliance
on in vitro cell culture methods that fail to replicate complex biological structures, while in vivo cell cultures use
animal models that have disparate physiology from humans. As a result, there is a gap in fundamental knowledge
surrounding how cells respond to various stimuli (or cues), limiting our ability to understand and fight illness.
Filling this gap necessitates new precision processes to create 3D structures that emulate the natural ECM for
in vitro cell culture. Herein, a feedback loop between digital light processing (DLP) 3D printing and cell studies
will provide new process-structure-function relationships between the technology to create biomimetic scaffolds
and concomitant cell-matrix interactions. Open fundamental questions to be addressed herein include: 1) To
what extent does using visible and near infrared light in DLP 3D printing improve cell viability and metabolic
activity over using UV light? 2) What are the optimal microscopic mesh sizes and macroscopic pore geometries
to facilitate uniform cell morphology and proliferation? 3) How does the layered topography of DLP 3D printed
structures influence cell behavior (e.g., adhesion, mobility, and differentiation)? 4) How do cells respond to sharp
vs. smooth interfaces where a cue is transitioning (e.g., stiffness gradients)? 5) How do cellular responses vary
for individual vs. combined mechanical and biochemical cues? Answers to these questions will be accomplished
using human mesenchymal stem cells (hMSCs) as a model system given their multipotent versatility and
microenvironment sensitivity that is representative of many cell types. DLP 3D printing was selected as the
fabrication platform owing to its unparalleled combination of speed, resolution, and low cost. However, this
technique to-date has been predominantly restricted to harmful UV light exposure, toxic acrylic resins, and the
production of rigid homogeneous parts that differ from the vital heterogeneity and softness present in many
ECMs. The Page lab is uniquely positioned to address these issues given their existing expertise and
infrastructure that will enable integration of heterogeneity into biomimetic structures by using benign visible to
near infrared (multi-)color and intensity (grayscale) light projection. This will allow for precise 3D spatial control
over network structure, mechanical properties, and protein tagging. hMSCs will be directly encapsulated in
synthetic ECM mimetics that emulate tissues ranging in stiffness from lungs (“supersoft”) to ligaments (“hard”).
Additionally, localization of proteins (e.g., growth factors) will be used to direct adhesion, movement, and growth
of hMSCs. Cell viability and behavior within the 3D scaffolds will be systematically characterized to elicit
structure-function relationships that address the above fundamental questions and that will inform further
bioprinting optimization and cell culture. If successful, this work will provide a platform to improve our capability
to monitor, diagnose, and treat diseases in a non-invasive in vitro manner.

Public health relevance
PROJECT NARRATIVE Modern medicine relies on our ability to effectively interface synthetic materials with biology to facilitate disease monitoring, diagnosis, and treatment. The contemporary reliance on monolithic 2D cell culture fails to capture the complex, 3D biological environment and thus precludes our ability to accurately study cell behavior and manage illness. The proposed research addresses this grand challenge through creating novel multifunctional matrices via color- and intensity-selective 3D bioprinting of tissue mimetics and directly studying cellular responses to local changes in shape, stiffness, and chemical signals within them.